Very Preterm Birth and Cortical Expansion in Early Life

Project Summary
From infancy to adulthood, the human cortex expands three-fold, with consequences for cognition and behavior.
While preclinical and histological research suggests that cortical expansion is driven by underlying
microstructural processes including dendritic arborization and synaptogenesis, it remains poorly understood
whether patterns of expansion reflect underlying changes in cortical microstructure in human samples.
Importantly, this key developmental process of cortical expansion may have clinical implications, as surface area
(the end result of expansion) has been linked to both cognitive and psychiatric outcomes in numerous clinical
populations. Thus, work exploring the biological underpinnings and functional consequences of cortical
expansion in early childhood is critically important. Children born very preterm (VPT; prior to 32 weeks gestation)
are a population of specific interest, as they experience increased rates of aberrant brain development as well
as comorbid ADHD, autism, and anxiety and impairments in executive functioning (EF) in childhood. Further still,
previous work has shown that over the first decade of life, they experience altered expansion in association
cortices known to be important for cognitive and psychiatric functioning. However, it remains unclear if these
alterations in cortical expansion relate to changes in cortical microstructure and if these patterns of altered
expansion underlie the increased rates of EF and psychiatric difficulties common in VPT children. The current
proposal will leverage ten years of unique existing data from a highly valuable, prospective, longitudinal cohort
of 52 VPT and 41 full-term (FT) children (currently being studied through R37 MH113570) to address these gaps.
It is hypothesized that decreased cortical expansion in association cortices will predict greater EF and psychiatric
impairments at age 10 years, and that these patterns of expansion will be predicted by cortical microstructure
differences already visible in infancy. To test this, in Aim 1, the applicant will innovatively analyze both
longitudinal diffusion and structural imaging data to define the relationship between spatial patterns of cortical
microstructure and patterns of cortical expansion in VPT and FT children. In Aim 2, the applicant will determine
how individual differences in cortical expansion relate to EF and psychiatric functioning at age 10 years in the
same sample. By identifying brain-based risk factors for cognitive and psychiatric impairments, this work will
expand our understanding of how the brain develops and could facilitate the creation of more targeted, early
treatments for at-risk children. Importantly, this proposed project will allow the applicant to develop her skills in
diffusion neuroimaging, longitudinal data analysis, scientific communication, and child psychiatry under the highly
valuable mentorship of Drs. Cynthia Rogers and Chris Smyser at Washington University. This will provide the
candidate with a strong foundation as she pursues her ultimate goal of becoming an academic child psychiatrist
who studies how early interventions support brain development and improve psychiatric functioning in children.

Public health relevance
Project Narrative Children born very preterm (prior to 32 weeks of gestation, 2% of the population) have both a 3-4-fold increased risk for psychiatric disorders and high rates of cognitive difficulties, yet the reason for this is not well understood. This proposal innovatively leverages ten years of data from a unique longitudinal cohort of very preterm and full- term children to investigate cortical expansion (a fundamental process in brain development) as a possible explanation for the high rates of cognitive and psychiatric impairments evident in this population. This work would help with early identification of at-risk children and facilitate the development of more targeted treatments aimed at improving the lives of children born very preterm.